Leadership, Planning and Evaluation

Senior leadership for Roswell Park Cancer Comprehensive Cancer Center works collaboratively to implement critical planning and evaluation processes that include recruitment efforts, research initiatives, clinical trial growth, educational programs, and operational objectives as outlined in the strategic plan responsive to our catchment area. Candace Johnson (DT), as the CCSG Director and President and CEO of Roswell Park, has ultimate authority over space allocation, finances, strategic initiatives, and clinical and scientific operations. She is joined on the CCSG leadership team by Renier Brentjens (TII) as Deputy Director and eight Associate Directors, who collectively possess valuable experience that encompasses all aspects of basic, clinical cancer research, cancer prevention and control, cancer education and training and community outreach. Completed in 2023, the CCSG strategic planning process culminated in a dynamic strategic plan built with input from both programmatic and senior leadership. The strategic plan includes key objectives to ensure the continued delivery of exceptional scientific research, education and clinical care and is directly responsive to community partner recommendations. Business planning metrics and benchmarks were incorporated to provide the senior leadership team with effective mechanisms to continually evaluate success. Leadership, planning and evaluation efforts rely upon key internal advisory committees, community members, and external advisory boards, which inform leadership about important local, regional and national issues impacting the cancer center. There are 4 main committees that provide input into strategic decision making: 1) The bi-weekly Strategic Council meeting that includes both senior leadership of the cancer center and the Associate Directors, 2) the monthly CCSG Steering Committee with Associate Directors, Program Leaders, select Shared Resource Directors, and other contributors to set directions for cancer center planning. 3) The annual External Advisory Board meetings which provide critical feedback and guidance regarding programmatic direction, shared resources and research progress. In addition, individual program advisory boards meet every 12 months and help guide decisions on revisions to programmatic aims and ways to foster community engagement. And 4) the Community Advisory Board which meets quarterly to discuss catchment-level issues impacting the broader community around the medical campus as well as to guide the programmatic direction of the center as it relates to the community. In addition to these 4 main committees, the Associate Directors lead committees to engage faculty in their specialty areas to ensure there is bi-directional communication occurring among all levels of the cancer center. At its core, leadership, planning and evaluation are the foundational ingredients that have and will continue to drive Roswell Park to achieving its strategic goals in the upcoming renewal period.